Preventing Suicide Among Female and Male Veterans Not Receiving VHA Services

BACKGROUND: Veterans are at elevated and increasing risk for suicide, relative to civilians. In particular,
female Veterans are nearly twice as likely to die by suicide, compared to female civilians. In addition, 70% of
Veterans who died by suicide did not use any Veterans Health Administration (VHA) care in the year before
death. Consequently, female and non-VHA Veterans have been identified as two target populations in the VA
National Strategy for Veteran Suicide Prevention. Yet most suicide prevention research has focused on VHA
users and male Veterans. Knowledge is thus limited regarding whether VHA and non-VHA users differ with
respect to who dies by suicide, precipitating circumstances of death, and regarding gender differences within
these domains. Moreover, while mental health (MH) care offers an important opportunity to recognize and
intervene upon suicide risk, knowledge is limited regarding barriers to accessing MH or suicide-specific care,
particularly in relation to whether these differ by gender or VHA use. These gaps preclude determining the most
effective and patient-centered means of preventing suicide among both female and male Veterans, particularly
those who not using VHA care. SIGNIFICANCE/IMPACT: The present study has strong implications for
understanding and preventing suicide among non-VHA users and female Veterans, both of whom have been
vastly understudied. This is particularly crucial considering: (1) the 2016 Female Veteran Suicide Prevention Act,
which directs VA to determine the most satisfactory and effective MH and suicide prevention programing for
female Veterans; and (2) the 2019 Executive Order on a National Roadmap to Empower Veterans and End
Suicide, which directs VA to work side-by-side with communities to reduce suicide among all Veterans, not only
those using VHA services. This study will increase knowledge of female and male Veterans who died by suicide,
including circumstances surrounding death, and the extent to which suicide decedents accessed MH care prior
to death. Such knowledge can be garnered to tailor prevention efforts across Veteran groups. Moreover, by
engaging with living Veterans, this study will improve understanding of Veterans’ experiences and willingness to
seek MH care in general and when suicidal, while also informing the extent to which their experiences, barriers,
and preferences differ by gender and VHA use. This knowledge is timely and critical as VA seeks to engage
more Veterans in care. INNOVATION: This study will be the first to identify factors differentiating VHA and non-
VHA suicide decedents and to explore female and male Veterans’ experiences and preferences for seeking help
when suicidal. This study is also innovative in conceptualizing non-VHA users as comprising Veterans who were
lost-to-care and who never used any VHA care. SPECIFIC AIMS: This study uses mixed-methods to compare
three groups of Veterans (VHA users, never users, and lost-to-care) across three aims: (1) Identify factors that
differentiate Veteran suicide decedents (e.g., circumstances of death, MH care use); (2) Examine differences in
willingness to seek MH care, barriers to using MH care, and MH care experiences; and (3) Describe and compare
Veterans’ experiences, preferences, and barriers to help-seeking when suicidal. Gender differences will be
examined across aims. METHODOLOGY: For Aim 1, probabilistic linkage of data from national sources will be
combined for Veteran suicide decedents to evaluate circumstances of death (e.g., interpersonal and
socioeconomic stressors, MH problems), as well as VHA MH care use (for VHA and lost-to-care decedents). For
Aim 2, Veterans will be surveyed about their willingness to seek MH care, barriers to doing so, and MH care
experiences. For Aim 3, qualitative interviews will explore Veterans’ experiences, barriers, and preferences for
seeking help when suicidal. Female Veterans will be oversampled. IMPLEMENTATION/NEXT STEPS: Intended
impacts include greatly enhancing knowledge and facilitating new opportunities for implementing patient-
centered, gender-sensitive suicide prevention strategies for all Veterans. Findings will be consolidated, and key
stakeholder input obtained to propose actionable clinical and policy changes.

Public health relevance
Suicide rates have increased rapidly in Veterans not using VHA care, particularly among females. Yet understanding of the reasons for these increases and how to address them is lacking. To address this knowledge gap, this study compares male and female Veterans who never used VHA care, were lost to VHA care after previous use, and who are currently using VHA care. We will examine if Veterans in these groups differ regarding: (1) circumstances and precipitants to suicide among suicide decedents; (2) mental health care experiences, barriers, and willingness to seek help; and (3) experiences, preferences, and barriers to help-seeking when suicidal. This mixed-methods study will link national datasets for suicide decedents, survey living Veterans, and conduct qualitative interviews of Veterans who have experienced suicidal ideation or suicide attempts. Gender differences will be examined to inform gender-sensitive, patient-centered suicide prevention efforts. Findings will be used to inform suicide prevention efforts for all Veterans, with an emphasis on non-VHA and female Veterans.